Assessing Patient and Community Engagement in Data Governance

ABSTRACT
The University of California, San Francisco (UCSF) Clinical and Translational Science Institute (CTSI) has a
strong track record of building infrastructure, securing resources, and fostering and supporting a diverse,
transdisciplinary workforce who share a vision and mission to accelerate research to improve health. Now in
the first year of its most recent renewal, CTSI is working toward the related goals of (a) fully incorporating
community stakeholders into clinical and translational research and (b) creating a responsible, community-
informed regulatory framework for guiding the use of personal health information for research. These efforts
are informed by recent calls for data oversight mechanisms that address the limitations of focusing exclusively
on individual consent and risk disclosure as strategies for protecting patients and research participants. New
approaches include shared governance models in which multiple stakeholders – including patients and
community representatives – contribute to decisions about the sharing and use of clinical and patient data.
Shared governance promises greater accountability and transparency, but little is known about attempts to put
it into practice including how institutional factors enable and/or limit meaningful patient and community
participation. This bioethics supplement will extend CTSI's aims by closely examining UCSF's culture of data
sharing. A culture of data sharing is a dynamic system of stakeholder groups, their interests, and the rules,
norms and tools guiding how patient data are produced, maintained and used. The objectives of this project
are to (a) elucidate the culture of data sharing and how it influences patient and community involvement in data
policy decisions, and (b) help guide UCSF and other health sciences institutions toward shared governance.
We will accomplish these objectives through a rigorous combination of empirical and normative aims. First, a
qualitative study will examine institutional values, priorities and practices pertaining to patient data, and the
extent and quality of patient and community involvement in data governance. Then, findings from the study will
be used to develop a framework that details the specific commitments, actions and relationships that foster
public engagement and a more inclusive and trustworthy culture of data sharing. The framework will augment
UCSF CTSI's efforts to enact shared data governance and will help institutions engaged in translational
science research and learning health system development incorporate significant and meaningful public
involvement in data policy decisions.

Public health relevance
NARRATIVE Medical breakthroughs and innovations increasingly depend on the aggregation, sharing and analysis of large quantities of personal health information. The shift to big data science has prompted calls for greater transparency and accountability in data use policies and increased patient and community participation in decisions about how data are used. This research will produce important knowledge about how institutional rules, norms and practices inhibit or promote meaningful public involvement in data policy making, and it will result in a framework designed to help health science institutions more effectively implement models of shared governance.